MULTISLICE IMAGING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Under the direction of Dr. G. Allan Johnson, test multislice sequence with short TE. Compare SNR, TE for specific field of views against the product multislice sequence. 1) Short TE, Multislice, Cartesian 2) Short TE, Multiecho, Multislice, Cartesian 3) Short TE, Multiecho, Multislice, Projection